Decoding Mitochondrial AAA Protease Specificity

The removal of misfolded, damaged, and regulatory proteins by AAA proteases is essential
for maintaining cellular integrity and health across all kingdoms of life. Disruptions in this process can lead to
cellular dysfunction and the accumulation of cytotoxic protein aggregates. Mitochondrial protein quality control
is particularly crucial, as proteins within the inner membrane and matrix are highly susceptible to oxidative
damage. To prevent inappropriate protein degradation, substrate selection by AAA proteases is tightly regulated.
It is thought that these enzymes primarily recognize unstructured sequences at the C- or N-termini of target
proteins, using ATP hydrolysis to unfold substrates and translocate them into the proteolytic chamber of a
peptidase for degradation. Adaptor proteins add an additional regulatory layer by either promoting or inhibiting
the degradation of specific substrates. However, the precise mechanisms by which these enzymes maintain
substrate specificity, interact with adaptors, and target substrates under different cellular conditions remain
poorly understood. This proposal seeks to elucidate the mechanisms of substrate recognition and adaptor mediated
degradation by soluble human ClpXP and membrane-bound m-AAA and i-AAA proteases, along with
their accessory adaptors. Mutations in these proteases have been linked to various neurological disorders, and
human ClpXP (hClpXP) has emerged as a promising therapeutic target in cancer treatment. Despite the high
sequence similarity between bacterial and hClpXP, the mechanisms of substrate recognition and adaptor
interaction in the human complex remain unclear. The mechanism by which membrane-bound AAA proteases
recognize and degrade both soluble and membrane protein substrates is notably murky.
To address these gaps, we will employ a multidisciplinary approach, integrating structural biology, biochemical
analysis, genetics, and mass spectrometry to understand the mechanisms of substrate specificity and processing
by these enzymes. Pulse-labeling mass spectrometry and genetic approaches will be used to identify substrates
for each AAA protease and quantify degradation rates in vivo. This will be followed by biochemical reconstitution
of a subset of these substrates in degradation assays to identify degron sequences and understand how adaptors
influence substrate recognition and degradation by AAA proteases. Finally, we will determine the cryo-EM
structures of these complexes, along with their cognate adaptors, in substrate-free and during substrate
recognition, recruitment, and unfolding. Given that many aspects of these degradation mechanisms are still not
well understood, the MIRA award will allow the Pl to allocate more time and resources to bridging this knowledge
gap while also focusing on training and mentoring a diverse group of scientists. This research will offer critical
insights into substrate specificity and adaptor-mediated proteolysis, carrying significant implications for both
fundamental science and therapeutic advancements.

Public health relevance
Understanding how AAA proteases and their adaptors collaborate to degrade specific proteins in mitochondria could provide valuable insights into mitochondrial protein surveillance. This research may reveal the etiology of diseases like Perrault syndrome, characterized by hearing loss and ovarian failure due to mutations in genes encoding hClpXP protease. It could also shed light on neurological disorders linked to mutations in m-AAA and i-AAA proteases.